Pediatric Cancer Data Commons Harmonization

Pediatric cancer research data availability and access is limited due to the rarity of pediatric cancers. To assist in overcoming these difficulties, the Pediatric Cancer Data Commons (PCDC) collects, aggregates, and makes available pediatric cancer research data for use by the research community. This data commons is a resource for collections of information related to clinical trials that is connected to other data sources in a cloud-based environment with associated data use tools. This effort will improve collection, access to, and use of pediatric cancer data and increase the effectiveness of research efforts and improve patient outcomes. This effort directly supports Childhood Cancer Data Initiative (CCDI) to increase research capabilities to develop improved pediatric therapies with the goal of reducing the incidence of and curing cancer. The objective of this project is to acquire program and technical informatics support services for clinical research data harmonization and integration; establishing infrastructure; data transfer and migration from multiple specialized databases; data quality assessment and assurance; and acquire required program management support.